Investigating the basis of MAIT cell antigen potency

SUMMARY
Mucosal Associated Invariant T (MAIT) cells comprise up to 10% of human peripheral blood T cells, and are
enriched in the liver, lungs and gastrointestinal mucosa. This indicates that MAIT cells are key players in
immunity. However, their roles in immune protection, and in immunopathology are yet to be fully established.
Nevertheless, MAIT cells are implicated in chronic inflammatory diseases including tuberculosis, peptic
ulceration, periodontal disease and inflammatory bowel disease. Central to the function of MAIT cells is the MAIT
T cell antigen receptor (TCR). Consistent with their innate-like phenotype, MAIT cells express a very restricted
T cell repertoire. Namely, human MAIT cells are characterized by an invariant TCR a-chain (TRAV1-2-TRAJ33)
paired with a limited array of TCR b-chains (TRBV6 or TRBV20). The MAIT TCR is restricted to the monomorphic
Major Histocompatibility Complex class I related protein, MR1. A very high level of conservation of MR1 in
mammals and the restricted MAIT TCR usage strongly indicate an important and evolutionarily conserved
function for the MAIT TCR-MR1 axis in immunity. Based on our previous work and preliminary findings, we aim
to: (i) Investigate novel MAIT cell antigens and their impact on MAIT TCR diversity; (ii) Define the cellular
machinery involved in acquisition and presentation of MR1 antigens; (iii) Investigate the structural basis of MAIT
cell antigen potency and selectivity. Our proposed studies will advance our understanding of MR1 presentation
and subsequent recognition by the MAIT TCR, which is a fundamental precursor for harnessing MAIT cells for
future immunotherapeutics.

Public health relevance
NARRATIVE Mucosal Associated Invariant T (MAIT) cells are an abundant population of T cell in humans. Presently, we know very little about the function of MAIT cells, their role in protecting humans from microbial infection, or how they may cause disease (e.g. autoimmunity). This proposal will shed fundamental insight into the nature of the antigens that can activate or inhibit MAIT cell function.